Demonstrating the Feasibility of Democratized Push-Button Autonomous Cardiac MRI exam in Community Family Health Centers (AutoCMR for FHC)

PROJECT SUMMARY
The overall objective of this proposal is to show the feasibility of democratized and comprehensive cardiac
imaging protocol using the combination of a push-button, time-resolved 3D cardiac magnetic resonance
imaging protocol (AutoCMR) and automated report generation (CMR-TARGET) for the purpose of heart failure
(HF) diagnosis in underserved community family health centers (FHC). The proposed end-to-end CMR
protocol will enable CMR to be used at FHC sites which currently are unable to support CMR. CMR is an
extremely complicated test to both operate and interpret. Operators need to be highly knowledgeable about
MRI physics and cardiac anatomy to identify optimal viewing planes and scan parameters. The study itself is
long and demanding on the patient requiring potentially dozens if not hundreds of breath-holds, something
extremely difficult for patients with HF. Reading the study is also highly specialized, requiring hundreds of
hours of additional training. Therefore, CMR is often limited to only a few major hospitals or highly specialized
clinics, leading to disparities in rural and urban minority populations. Without access to advanced imaging,
diagnosis and prognosis of HF leads to worst outcome. With this work, we hope to show increased access to
CMR at regional sites using the two proposed technologies (AutoCMR and CMR-TARGET) and specifically
show increased accessibility to CMR in the aforementioned disadvantaged populations.

Public health relevance
PROJECT NARRATIVE This proposed project has three key aims that together will work towards democratizing access to advanced cardiovascular MRI imaging for underserved community family health centers to diagnose heart failure. The proposed project’s aims include validation of an automated push button cardiac MRI protocol, extension of the protocol to target key HF populations, and reducing documentation burden for interpretation.